Inflammatory and Genetic Cardiomyopathies: Metabolic Phenotyping to Guide Diagnosis and Therapy

Cardiac sarcoidosis (CS) is both under- and over-diagnosed. While vigilance has increased, diagnosis of
isolated CS (ICS) remains challenging as detecting granulomatous inflammation on endomyocardial biopsy
(EMB) is low yield. Thus, ICS is often presumed based on positron emission tomography (PET), the use of
which has been proliferating. Thus, in an attempt not to under-diagnose CS, we are:
1) mis-diagnosing patients with “ICS” who actually have genetic CMP (36% in our prior work), with major
clinical implications including unnecessary immunosuppression and failure to screen family members
2) identifying a growing group of “idiopathic 18FDG-avidity” patients” (64%) who have neither CS nor genetic
CMP in whom identifying mechanism of 18FDG-avidity will guide future therapeutic options
In this “bedside to bench” translational proposal, we perform “deep phenotyping” with genetic testing, PET
imaging, metabolomic studies, voltage-guided EMB (with advanced inflammation histology methods) to:
1) help clinicians decide in which patients to order genetic testing and PET scans
2) develop minimally invasive diagnostic tests to determine mechanism of 18FDG-avidity and therapeutic
options in patients with “idiopathic” or genetically-driven 18FDG-avidity
In Aim 1, a total 200 patients will systematically undergo PET and genetic testing to help determine
revalence and predictors of true CS, genetic CMP and “idiopathic 18FDG avidity”, and we will develop a
prediction model to guide clinicians when to order genetic testing and PET scans. In Aim 2.1, we will
metabolically phenotype these patients by simultaneously sampling radial artery and coronary sinus blood and
using mass spectrometry to quantify myocardial fuel use, testing our hypothesis that the 18FDG-avidity in
genetic CMP and idiopathic 18FDG-avid patients is due to a “metabolic switch” from fatty acid (normal) to
glucose metabolism, and not due to inflammatory cell infiltrate. We will also measure and correlate
inflammatory cytokines and oxygen consumption rate and extracellular acidification rate with metabolic data to
help develop a “non-invasive signature” of true inflammation versus metabolic switch. To test the inflammatory
counter-hypothesis, in Aim 2.2 we will process EMBs of “idiopathic 18FDG-avidity” patients and positive (true
CS) and negative (18FDG-negative) controls using multi-spectral immunostaining, spatial transcriptomics, and
imaging cytometry, which historically differentiate CS from its mimicking conditions.
In Aim 3, cardiomyopathy mouse models will be utilized on our 18FDG-PET scan protocol to allow us to
further study this phenomenon with even greater anatomic detail and control than in humans, and eventually to
allow testing of novel therapies for this condition. In addition to providing predictive tools and novel diagnostic
tests, elucidating the mechanism of 18FDG-avidity will enable future animal and human studies of
immunosuppression and/or metabolic therapies for this growing group of patients and their families.

Public health relevance
Project Narrative Many patients with the combination of structural heart disease and heart rhythm disorders have either a genetic cause or inflammatory cause (immune system attacking the heart), but these can be challenging to diagnose. This proposal systematically studies such patients with genetic testing, advanced cardiac imaging, blood-based studies of metabolism and heart tissue biopsy with next-generation histology/pathology methods to help create new diagnostic tests. Correctly diagnosing these patients will help clinicians not only provide necessary treatment, but also stop unnecessary immunosuppression, and refer patients’ family members for “cascade” genetic testing when necessary; and a parallel mouse study utilizing genetic models of heart disease will allow study of novel therapies for these conditions.